Development Funds

DEVELOPMENTAL FUNDS – PROJECT SUMMARY/ABSTRACT
Developmental Funds support two University of Virginia Cancer Center (UVACC) activities: Faculty
Recruitment and Pilot Research Projects. These activities enable the UVACC to implement its long-term
strategic goals, which depend on recruiting the best people and on supporting them, as well as existing faculty,
to perform the highest quality cancer-focused research. The exceptional quality of the new recruits and the
multiple positive Pilot Research Project outcomes—as measured by resulting research papers, peer-reviewed
grants, and clinical trials—all bear witness to the success of UVACC Developmental Fund investments. Such
accomplishments reflect the sound stewardship of these funds. In addition, the success has served as a
stimulus for obtaining additional philanthropic support for developmental activities, thus leveraging NCI dollars.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.